ProAgio in Pancreatic Cancer

SUMMARY/ABSTRACT
Cancer associated fibroblasts and pancreatic stellate cells (PSC/CAF) and abnormal tumor blood vessels are
two major factors that contribute to treatment failure. PSC/CAF contribute to the collagen-rich extracellular matrix
(ECM) which impairs drug delivery, promotes cancer cell survival and contributes to an immunosuppressive
environment. CAF have been shown to have a similar role in supporting metastatic sites of disease in
PDAC. Currently, no agent is available that can simultaneously selectively reduce activated PSC/CAF and
normalize angiogenesis. Both activated PSC/CAF and angiogenic endothelial cells selectively express high
levels of integrin v3. There is no expression of integrin v3 in normal tissue. We developed ProAgio, an
innovative protein drug with a distinct mechanism of action from currently available integrin-targeting agents in
targeting integrin v3 at a novel non-ligand binding site. ProAgio induces apoptosis of integrin v3
expressing PSC/CAF and angiogenic endothelial cells with a high efficiency by recruiting and activating
caspase-8 at the cytoplasmic domain of. Our preliminary data shows ProAgio has anti-tumor activity in
multiple PDAC models and enhances the effect of gemcitabine. Histologic analyses showed ProAgio decreased
collagen and depleted PSC/CAF in tumors. In a phase I clinical trial, single agent ProAgio has demonstrated
excellent safety profile, promising pharmacokinetic profile and anti-tumor activity in patients with PDAC.
We hypothesize that, by inducing apoptosis of integrin v3 expressing cells, ProAgio will specifically deplete
both angiogenic endothelial cells and activated PSC/CAF leading to inhibition of collagen deposition in PDAC
tumors, which will enhance drug delivery and increase the sensitivity of PDAC to established therapies. This
Project has three Specific Aims: 1) To characterize the toxicity and determine the recommended phase II dose
of ProAgio in combination with gemcitabine and nab-paclitaxel. We will conduct a phase I clinical trial of ProAgio
in metastatic PDAC patients with no prior therapy with gemcitabine and nab-paclitaxel. The goal is to determine
the recommended phase II dose, evaluate pharmacokinetics of ProAgio, and characterize toxicity. A secondary
objective is to obtain preliminary activity data (overall response rate) for ProAgio with gemcitabine and nab-
paclitaxel in PDAC. 2) To analyze the effect of ProAgio in patient tumors and validate the mechanism of drug
action. PDAC patients enrolled in the expansion phase will undergo paired pre- and post-treatment biopsies. We
will validate mechanism of ProAgio action by assessing changes in intratumoral collagen, blood vessels,
PSC/CAF subtypes, immune cells, and αvβ3 expression in these patient samples. Samples will be analyzed via
multiplex immunofluorescence with spatial quantification and single cell RNA sequencing. 3) To evaluate the
pharmacodynamics effects of ProAgio on angiogenesis and tumor perfusion. The perfusion changes in tumors
after treatment with ProAgio plus chemotherapy will be measured using quantitative DCE-MRI in all patients.

Public health relevance
PROJECT NARRATIVE In this application, we will conduct a phase I clinical trial testing the safety of a novel agent that targets an integrin that is expressed at high levels in pancreatic cancer stroma. This new drug will have a dual effect on the stroma by targeting both cancer associated fibroblasts and blood vessels that aid the cancer in progression. As part of the clinical trial we will collect patient tissue and blood to determine how this novel therapy acts on cells, and evaluate the effects on blood flow to the tumor using MRI.